EPR OF THE MN SITES IN MN CATALASE AND PHOTOSYSTEM II

Redox reactions are central to life processes. In carrying out redox reactions, proteins show rates and selectivities that are unrivaled by conventional chemical systems. The proposed sabbatical research is part of an on-going effort to understand, at the molecular level, the mechanisms of Mn redox enzymes. Particular emphasis is placed on Mn catalase and on the photosynthetic oxygen evolving complex (OEC). The former is a cellular detoxification enzyme found in some bacteria, while the latter is the source of most of the oxygen in the atmosphere. The long term goal of this work is to understand the properties of these multinuclear Mn sites in sufficient detail that it will be possible to rationally control the reactivity of synthetic mimics of these sites. The proposed collaboration will take advantage of unique instrumentation and expertise that are available at Saclay. These will be used to measure multifrequency electron paramagnetic resonance (EPR) spectra for Mn catalase in the reduced, oxidized, and superoxidized oxidation states, both with and without added anion inhibitors. These will permit more detailed characterization of the Mn catalase active site and the Mn catalase mechanism. Low temperature infrared illumination will be used to explore the structural rearrangements that are possible for the Mn catalase site. This provides a model to help understand similar reactions in the OEC. Finally, several newly characterized derivatives of the OEC will be studied by high-field EPR, in order to better define their electronic properties.